SCH: A Sensing Platform Monitoring Interactions with Daily Objects to Assess Real-World Motor Performance in Stroke Survivors

Stroke is the leading cause of disability in adults worldwide. Upper-limb paresis is the most common
impairment post-stroke. The ultimate goal of stroke rehabilitation is to improve patients’ motor
performance in their home and community settings (i.e., what patients actually do). However, current
clinical standards to monitor patients’ recovery process are limited to assessing patients’ motor capacity
observed in the clinic (i.e., what patients are capable of doing). Wrist-worn accelerometers have been
considered as a potential solution but criticized for providing a limited view of upper-limb performance.
Therefor, the research and clinical communities have emphasized the need for a technological solution to
support a more comprehensive understanding of stroke survivors’ motor performance.
In this work, we propose to develop a novel multi-modal sensing platform to monitor important elements of
upper-limb motor performance: the amount, type, and quality of movements. To that end, we introduce a
new kind of sensing technology, namely Body Channel Identification (BCID), that can accurately and
reliably track human interactions with the environment and, thus, human behaviors. In our setting,
everyday objects are instrumented with small, inexpensive, batteryless BCID tags that can be powered by
and communicate with wrist-worn devices (so-called readers) by exploiting the human body as the signal
transfer channel during tactile interactions. The system provides multi-modal data, including the object ID,
binary time-series of interaction patterns (contact vs. no contact), kinetic data from an optional pressure
sensor embedded in the tag, and kinematic data from the inertial measurement unit on the wrist-worn
readers. Leveraging data obtained from 50 stroke survivors and ten healthy subjects, we propose to
develop a unique set of machine learning algorithms to process these data to taxonomically identify
important types of upper-limb movements relevant to stroke rehabilitation, which are further processed to
assess the quality and amount of movements performed. Finally, we investigate the relationship between
the motor capacity observed in the clinic vs. motor performance outside the clinic, a topic that has been
deemed critical in stroke rehabilitation but infeasible due to technical limitations. We believe the proposed
research will lay the technological groundwork to open up new research and clinical opportunities, leading
to key scientific discoveries to transform current practices of stroke rehabilitation.

Public health relevance
This study proposes to develop a novel multi-modal sensing platform to monitor stroke survivors’ upper-limb performance in their naturalistic environments. The outcomes of the proposed research project could impact nearly 800,000 Americans undergoing stroke rehabilitation each year—more broadly, patients suffering from hemipareses, such as traumatic brain injuries and multiple sclerosis—by enabling personalized rehabilitation programs focusing on motor performance.